Undetectable and Untransmittable: reducing HIV transmission among young women living with HIV, their partners and children in South Africa

PROJECT SUMMARY
Candidate: Dr. Toska is steadfast in her commitment to support young women living with HIV in lower- and
middle-income countries (LMICs) to survive and thrive, which includes developing interventions that enable them
to adhere to ART, engage in healthy sexual relationships, and plan safe pregnancies. Her career development
plan focuses on: 1) cultivating scientific expertise to investigate sexual and reproductive health resilience, a
concept developed for this award, 2) gaining knowledge on developing socio-behavioral interventions for young
women living with HIV, and 3) expanding leadership and mentorship skills. These objectives will be realized
through the support of highly-experienced mentors, who are global scientists in research on HIV, adolescents
and young people, and sexual and reproductive health in LMICs. Through this award, Dr. Toska will consolidate
her career goal of becoming a global leader in socio-behavioral interventions to reduce onward HIV transmission
among young people living with HIV in LMICs.
Research: Reducing onward HIV transmission among young women living with HIV in LMICs is central to
breaking the cycle of transmission, by addressing both vertical (mother-to-child) and horizontal (sexual)
transmission to partners. Global HIV prevention efforts to date focus on supporting all people living with HIV to
stop onward HIV transmission through viral suppression (Undetectable=Untransmittable). Growing evidence has
documented how young women living with HIV experience poorer HIV treatment outcomes, higher rates of
unintended pregnancies and greater risk of passing on HIV to their children. No intervention addresses these
two aspects of U=U among young women living with HIV. The scientific goal of this K43 is to inform the
development of an evidence-based intervention that addresses the complex relationship ‘clusters’ that young
women living with HIV are part of, to reduce onward HIV transmission to their partners and children. The training
objective of this K43 is to obtain intensive mentoring and formal training on the foundational skills necessary to
develop an evidence-based intervention to stem onward HIV infection among young women living with HIV. The
specific research aims of this award are to 1) investigate predictors of onward HIV transmission, 2) develop
and validate a quantitative measure for sexual and reproductive health resilience, and 3) map causal pathways
between sexual and reproductive health resilience, unintended pregnancies, and viral suppression among young
women living with HIV. This award capitalizes on the intellectual and research infrastructure of two existing
cohorts, Mzantsi Wakho and HEY BABY, based in the Eastern Cape, South Africa. The study advances NIH
priorities by advancing science on HIV transmission in a highly vulnerable population, promoting the
development of an evidence-based interventions for HIV prevention for this population, and building capacity for
an LMIC emerging researcher and the early career researchers she will collaborate with.

Public health relevance
PROJECT NARRATIVE Global HIV prevention efforts are at a crossroads: a growing cohort of young women living with HIV is struggling to adhere to HIV treatment consistently and prevent unintended pregnancies, and are at a growing risk of passing on HIV to their partners and children. To support young women living with HIV to realize the goals of Undetectable=Untransmittable, we need a radical shift in how U=U is operationalized for this vulnerable population, including a strong understanding of how they engage in relationships with adults and their partners, and how these relationships shape their health practices and centering interventions on long-term resilience- building, rather than short-term risk reduction. This study addresses a critical gap in HIV prevention by laying the necessary scientific groundwork to develop effective and relevant interventions to reduce onward HIV transmission, through: (1) exploring factors associated with onward HIV transmission in the ‘relationship clusters’ that young women have, (2) conceptualizing and measuring sexual and reproductive resilience, and (3) mapping the causal pathways between predictors, resilience, and onward HIV transmission among young women living with HIV.